Perinatal metal mixture exposure and prenatal maternal stress: Impact on neural and cognitive constructs underlying adolescent risk-taking

PROJECT SUMMARY/ABSTRACT
Maladaptive adolescent risk-taking behaviors are a public health concern associated with a variety of adverse
health outcomes. Although studies have explored neurobiological mechanisms underlying adolescent
risk-taking, few have examined the potential role of early-life environmental exposures. To address this
knowledge gap, this proposal utilizes a Developmental Origins of Health and Disease (DOHaD) framework to
elucidate early-life environmental influences of adolescent-risk taking, focusing on the unique vulnerability of
the perinatal period (prenatal to 1 year postnatal). Throughout the perinatal period, the brain undergoes
significant structural and functional maturation, making exposures at any point a risk for abnormal
neurodevelopment. Converging epidemiological data suggest that individual metal exposures (e.g., lead,
manganese) during this period may contribute to adolescent-risk taking by disrupting the development of
subserving brain regions within the reward and/or cognitive control systems (e.g., striatum, prefrontal cortex).
However, although metals commonly co-occur in the environment, no epidemiological study to date has
assessed the impact of perinatal metal mixture exposure in relation to adolescent risk-taking. Furthermore,
evidence suggests prenatal maternal stress (PMS) may enhance metal neurotoxicity, suggesting that
combined exposure to PMS and metals may increase risk for maladaptive adolescent risk-taking. Yet, the
modifying effect of PMS on metal-associated outcomes has not been studied in the context of adolescent
risk-taking. This study proposes to examine associations between perinatal metal mixture exposure on
cognitive (Aim 1) and neural (Aim 2) constructs underlying adolescent risk-taking, and to evaluate the
modifying role of PMS on these associations (Aim 3). Using state-of-the-art statistical methods, I will analyze
existing data (dentine metal biomarkers, maternal stress measures, gambling task fMRI) collected from
adolescents enrolled in the Programming Research in Obesity, GRowth, Environment, and Social Stress
(PROGRESS) study. My analyses will focus on brain regions associated with reward, risk, and/or cognitive
control (e.g., ventral striatum, insula, dorsolateral prefrontal cortex), and the following constructs derived from a
computational model of risky decision-making: risk-taking tendency, risk sensitivity, reward sensitivity. I
hypothesize that perinatal metal mixture exposure will be significantly associated with alterations in these
constructs, and that these associations will be enhanced in offspring exposed to higher PMS. The proposed
project is supported by the Icahn School of Medicine at Mount Sinai’s Department of Environmental Medicine
and Public Health, which provides a highly cross-disciplinary research environment. By integrating
environmental epidemiology, biostatistics, and developmental cognitive neuroscience, the proposed research
presents a unique training opportunity in the growing field of environmental developmental neuroscience and
will prepare the applicant for an interdisciplinary academic research career. Importantly, the proposed research
will also inform public health interventions aimed at improving adolescent health.

Public health relevance
PROJECT NARRATIVE Early-life environmental exposures have been linked to alterations in brain regions and behaviors implicated in maladaptive adolescent-risk taking, yet their role in this phenomenon remains unclear. This project seeks to comprehensively examine the impact of perinatal metal mixtures and prenatal maternal stress on neurocognitive mechanisms underlying adolescent-risk taking, with the overall goal of elucidating early-life environmental influences of maladaptive risk behaviors in adolescence. This study will serve to delineate associations between early-life environmental exposures and distinct risk-taking constructs to inform future public health interventions aimed at improving psychological outcomes in adolescents, particularly those within highly exposed communities.